Neurobiological Signatures of Perception of Audiovisual Speech in Children with Autism Spectrum Disorders

Problems in receptive and expressive language in autism spectrum disorders (ASD) create significant barriers in cognitive and social development and in long-term outcomes, such as the ability to live independently. There is significant variability in language skills in children with ASD, ranging from an absence of functional verbal communication to relatively spared language (Kjelgaard & Tager-Flusberg, 2001; Paul, 2007; Tager-Flusberg, 2004). With reports of 1 in 68 children now identified as having an ASD (Centers for Disease Control, 2014), understanding the source of deficits in spoken language is crucial, as language skill is a key predictor of developmental outcome in this population (Venter et al. 1992). One candidate source of the observed heterogeneity in language is reduced looking to faces of others in children with ASD (e.g., Hobson et al., 1988; Klin et al., 2002). This limited gaze to the face may have cascading effects on language learning by reducing 1) access to the visible aspects of a speaker's articulations and 2) the likelihood of imitation of other's visible speech gestures. In the current proposal, sensitive neurobiological and behavioral techniques including event related potentials (ERP) and eye tracking will be paired with novel speech tasks to provide a window on the factors that underlie the perception of audio and visual (AV) speech in children and adolescents with ASD. This work extends our understanding of the behavioral and neurobiological underpinnings of AV speech perception, which may have important implications for the acquisition of spoken language. 1

Public health relevance
Problems with spoken language can be severely limiting for an individual with an autism spectrum disorder (ASD), impacting learning, social skills and in long-term outcomes, such as the ability to live independently. We propose that inattention to a speaker's face is a possible source of these language impairments. Using a non- invasive technique we will assess neural response and eye gaze to the face in children and adolescents with ASD while they watch videos of speakers producing syllables and words. 1